Sequence specific determinants, and impacts, of NS2 interactions with the influenza A virus polymerase

Influenza A virus (IAV) remains a threat. With high pandemic potential, and two circulating strains in human
populations, IAV has contributed to yearly morbidity and mortality despite its identification and isolation nearly
100 years ago in 1930. In addition to intense study of its surface proteins, hemagglutinin and neuraminidase
(and the surface-exposed loop of the viral ion channel) to identify relevant targets of adaptive immunity, there
have been considerable efforts to characterize the viral replication and transcription machinery. Such work has
recently led to the development of new antivirals, and using this information has also led to an improved ability
to leverage IAV as a vector in oncolytic therapy. In this proposal, we will expand on this prior work with a
particular focus on the interactions with, and effects of, NS2 on viral sequence.
The minimal IAV replication machinery consists of a heterotrimeric polymerase (PB1, PB2, and PA),
and viral nucleoprotein (NP). Transfection into cells of this machinery with an appropriate RNA template (or
polymerase I-driven plasmid expressing an appropriate RNA template) is sufficient to recapitulate both viral
transcription and genome replication. This results in the production of three molecules, vRNA (- sense viral
genomes), cRNA (+ sense viral antigenomes), and mRNA (+ sense viral transcripts). For IAV, mRNA
possesses a host-derived cap, snatched by the endonuclease subunit, PA, and a polyA tail that is generated
through a stuttering mechanism. While the minimal machinery is sufficient to produce all three molecules, it
does so in amounts that are quite different than during infection. One of the largest differences is that during
infection, each of the eight RNA segments comprising the IAV genome produces dramatically different
amounts of mRNA, which is not the case during transfection.
As an explanation for this divergence in behavior, it has been determined that expression of an
additional IAV protein, NS2, modulates transcription and replication. Specifically, NS2 broadly decreases
transcription in favor of replication. However, it does so unequally across the eight genomic segments of IAV,
more consistent with what is observed during infection. As the characterized, minimal, viral promoter is
identical across the eight IAV segments, this suggests NS2 must interact with an extended, uncharacterized,
promoter sequence. Moreover, whether NS2 plays any role beyond regulating this switch is unclear. In this
grant we will identify the sequence interface regulating NS2 interactions using a high-throughput mutation
approach that we have already trialed successfully, explore our preliminary results that NS2 may modulate viral
polymerase processivity, and, lastly, follow up on recent results from our group that NS2 may also impact viral
polymerase fidelity. By the completion of this grant, we will have redefined the replication and transcription
dynamics of IAV, providing novel interfaces for potential intervention, as well as providing essential information
to those seeking to develop artificial viral platforms for therapeutics.

Public health relevance
Project Narrative Influenza A virus must transcribe and replicate the eight RNA segments comprising its genome in a highly regulated fashion. In addition to the minimal viral replication machinery—the heterotrimeric polymerase and viral nucleoprotein—the influenza virus NS2 protein appears to play a segment-specific role in this process. By the completion of this grant, we will identify sequence-specific requirements for the engagement of NS2 as well as extended functions of NS2 in modulating viral polymerase processivity and error rate.